Interdisciplinary Immunology Training Program

PROJECT SUMMARY
The goal of the Yale Interdisciplinary Immunology Training Program (YIITP) is to equip predoctoral trainees
with the intellectual and research foundations necessary to become independent scientists/educators
investigating basic mechanisms of immune system development and function. The YIITP, which is entering its
46th year, combines rigorous research training in a highly interactive environment and a thorough academic
program of instruction in immunology and related disciplines with diverse opportunities for career and skill
development. The program leads to the PhD and offers training in virtually all aspects of immune system
development and function as well as host-microbe interactions and mechanisms by which the immune system
prevents and contributes to disease. The YIITP faculty is composed of 35 immunologists with outstanding
records of research accomplishment and training whose labs interact and collaborate extensively (114
collaborative publications in the last 5 years). YIITP Program Directors David Schatz and Carla Rothlin work
together closely in complementary roles to direct the program and together with four additional faculty,
constitute the YIITP Executive Committee, which develops new initiatives, evaluates program success based
on internal and external review, and oversees trainee and YIITP faculty evaluations and appointments. The
principal training entity is the Department of Immunobiology, whose graduate program has consistently been
among the top-ranked immunology graduate programs in the United States. YIITP students enter Yale
predominantly via application to the Immunology Track of the Biological and Biomedical Sciences (BBS)
Program and are selected for YIITP appointment in year 2 based on a research focus on basic immune
mechanisms. YIITP training involves formal course work, research rotations, teaching, and qualifying exam in
years 1-2, with thesis research beginning in the spring of year one. A longitudinal mentoring program begins in
year 1 and each student is assigned a thesis advisory committee in year 2. Training is enriched by intensive
training in rigor, reproducibility, and responsible conduct of research, travel to major immunology meetings,
extensive outreach, mentoring, and diversity engagement, and numerous opportunities for collaboration and
interaction. YIITP trainees publish at high rates in top-level journals and over 30% in the last 10 years have
won independent predoctoral fellowships. The YIITP has instituted 4 new initiatives to recruit and retain
trainees from diverse backgrounds in the last 5 years, and in the last 3 years, training grant eligible (TGE)
immunology applicant numbers have increased by 64% (to 144 in 2021) and those from under-represented
minority (URM) groups have increased by 100% (to 32 in 2021). Fully two-thirds of matriculating TGE students
in 2021 are URM. 100% of YIITP PhD recipients in the last 10 years have entered research intensive, research
related, or scientific teaching careers and trainee completion rates are high (~90%). This proposal requests
continued support for 10 predoctoral slots to support 5 trainees in each of years 2 and 3 of training.

Public health relevance
PROJECT NARRATIVE The Interdisciplinary Immunology Training Program at Yale University supports the education and training of the next generation of scientists who will study the fundamental principles of the immune system, the system of the body responsible for combating infectious diseases. Graduates from this program go on to leading positions in universities and industry, where they contribute to a deeper understanding of how the immune system functions with implications for the development of new vaccines, new therapies to combat viruses and bacteria, and new treatments for cancer, autoimmune, hypersensitivity and inflammatory diseases.